MOLECULAR APPROACHES TO VACCINE AND ANTIVIRAL DEVELOPMENT IN HEPATITIS C

Hepatitis C virus (HCV) is a leading cause of chronic hepatitis and hepatocellular carcinoma worldwide and infects more than 1% of the world[unreadable]s population. Successful vaccine development is pivotal in controlling this global health problem. A system for efficient assembly of HCV structural proteins into HCV-like particles (VLPs) in insect cells has been developed in our laboratory. These noninfectious HCV- like particles had similar morphologic, serologic and biophysical properties as the putative virions isolated from HCV infected humans. In contrast to recombinant subunit vaccines, the viral proteins of HCV- like particles may be presented in a native, virion-like conformation and may therefore be superior in eliciting a protective humoral and cellular immune response. Using HCV-LP as a capture antigen in an enzyme-linked immunosorbant assay (ELISA), anti-HCV antibodies were specifically detected in serum from individuals with acute and chronic HCV infection. The ability of the HCV-LP to elicit an immune response in vivo was studied in mice. A specific and broadly directed humoral immune response against the HCV structural proteins with appearance of anti-HCV antibodies was induced. HCV-specific cell-mediated immunity including proliferative and cytotoxic T cell responses, which have been shown to be important in controlling viral infection, was also induced in the HCV-LP immunized mice. We plan to conduct experiments in chimpanzees to test the effectiveness of the HCV-LP as a vaccine candidate. Studies have also been extended to full-length HCV cDNA. A full-length HCV genome that is infectious in chimpanzee has been obtained and used to generate a baculoviral expression construct. HCV polyprotein was expressed from the recombinant baculovirus with correct processing to yield all the structural and nonstructural HCV proteins at high levels. The nonstructural proteins form complexes in the perinuclear region of the insect cells possibly as a replicative intermediate, and can be partially purified. These complexes demonstrated RNA-dependent RNA polymerase activity. Experiments are underway to determine whether viruslike particles are produced in insect cells and whether the full-length HCV construct is able to replicate and generate infectious virions in this system. These studies will not only facilitate understanding of HCV replication but also may provide a tissue culture-based system for generation of candidate vaccines and screening of potential antiviral agents. - Viruslike particles/Immune response/Neutralizing Antibodies/CTL - Human Subjects